Pharmacokinetic Tomography for the Measurement of Topical Drug Product Bioequivalence

Project Summary
The lack of accurate and reliable techniques for visualizing and quantifying the delivery and uptake
(pharmacokinetics) of small molecules into the skin has been a major challenge in the development of both new
and generic topical drugs. This is particularly true in the measurement of bioequivalence, where a generic drug
candidate must be compared against a reference brand-label drug. Current methods, which rely on expensive,
destructive, and bulk measurements do not provide the spatial or temporal resolution necessary to extract
pharmacokinetic profiles to determine equivalence of drugs at the cellular level over time in human skin. New
tools, which allow for direct, real-time quantification of pharmacokinetics non-invasively in humans are needed
to drive innovation in the topical drug space.
Pharmacokinetic Tomography (PKT) is a method of generated three-dimensional, real-time maps of various
molecular species such as lipids, water, proteins and drugs in tissue using spectroscopic imaging techniques.
These imaging techniques make use of the intrinsic molecular vibrations of drug molecules to track their uptake
quantitatively without the need for labels or alterations to molecular structure. This proposal will develop new
coherent Raman imaging tools to create a platform for quantifying the behavior of drugs in ex vivo human skin.
This PKT-based platform will be able to measure the uptake of drugs such as antibiotics, kinase inhibitors,
steroids, retinoids and NSAIDs in the skin with sub-cellular and sub-second time resolution to glean critical
pharmacokinetic parameters needed for drug development and bioequivalence measurements. To compare PKT
to an FDA-recognized standard, these PKT imaging will be carried out alongside dermal open flow
microperfusion (dOFM), a skin fluid sampling technique that measures the concentration of drugs over time. The
multimodal PKT platform, when completed, will be able to measure the bioequivalence of various drugs in situ
in human subjects.
This research program will specifically develop new imaging toolkits that combine advanced microscopy with
state-of-the-art computer vision and machine learning analysis techniques to collect and extract pharmacokinetic
data. Using a new type of versatile laser, we will create a coherent Raman technique ideal for detection of drug
molecules which contain unique chemical structures. In order to broaden the applicability of the platform to a far
wider range of potential drug molecules, we will develop a sparse sampling coherent Raman imaging approach
that will quantify molecules by their unique combinations of molecular structures.

Public health relevance
The development and approval of topical generic drugs for treating dermatological conditions has been slow due to the difficulty and cost in establishing bioequivalence of potential drugs using existing pharmacokinetic profiling methods. For this reason, there is a major need for techniques that can enable the direct visualization and quantification of drugs as they flow and accumulate within tissue. This proposal seeks to develop Pharmacokinetic Tomography imaging tools that make use of the intrinsic molecular vibrational properties of drugs to create a platform translatable to human studies for the measurement of drug bioequivalence.